Administrative Core

The Cincinnati Children’s U19 Asthma and Allergic Diseases Cooperative Research Center (AADCRC):
Epithelial Genes in Allergic Inflammation program includes three tightly integrated projects, a Data Integration
and Analysis Core (DIAC), and an Administrative Core. Each of the projects in the Center is focused on distinct
epithelial cell genes and their roles in allergic disorders including asthma, atopic dermatitis, and eosinophilic
esophagitis. The central goal of the Administrative Core is to administer the program and provide the
infrastructure necessary for achieving the scientific goals of the project. The Specific Aims of this core are:
Aim 1. Program Administration and Management. The Administrative Core will be responsible for
administrative issues including scientific administration and coordination, monitoring of scientific progress, and
compliance with regulatory affairs. The Administrative Core will institute policies to resolve controversies among
investigators and members of the Steering Committee.

Aim 2. Program Communication. The Administrative Core will be responsible for coordinating communication
within the Program, as well as communication between the Program and our institution and between the Program
and the NIH.
Aim 3. Financial Administration and Budget Oversight. The Administrative Core will oversee all matters
related to the Program budget, as well as annual fiscal and scientific reporting responsibilities. We will leverage
the strengths and considerable resources of the institutional Schubert Research Center (SRC). The Program
budget includes significant cost savings subsidized by our institution and the SRC.
Aim 4. Infrastructure and Opportunity Fund Administration, if selected. The Program Administrative Core
will take responsibility for managing the AADCRC IOF and work with the CCHMC Sponsored Programs office to
establish a dedicated administrative structure within the Sponsored Programs infrastructure to administer all
aspects of the IOF including.